Attention-Related Neural Circuitry in Pediatric Anxiety and ADHD

Anxiety disorders are the most common form of pediatric psychiatric illness, affecting up to 30% and severely
impairing up to 20% of all youth prior to age 18. Unfortunately, up to 50% of children remain symptomatic even
with best available treatments, making anxiety disorders a major public health problem. To devise new
treatments for anxiety disorders, more research is needed into underlying brain mechanisms. Research
studying mechanisms suggests that anxiety disorders are linked to alterations in attention, including increased
attention to threatening stimuli (e.g., feared objects or sounds). However, more recent research suggests these
attention alterations may be due to a larger problem in which attention is increased to all stimuli (e.g., any loud
noise, flash of light, etc.). This alteration in attention seems to be the opposite of ADHD, the prototypical
disorder of attention in childhood and also a common childhood psychiatric disorder. In ADHD, children appear
to have a generalized decrease in attention to suddenly appearing stimuli (e.g., children with ADHD might not
hear their name called). Intriguingly, although anxiety and ADHD appear to demonstrate opposing attention-
related problems, these disorders occur in the same child more often than expected by chance. Understanding
the brain mechanisms underlying attention alterations in pediatric anxiety and ADHD is critical in designing
new treatments that attempt to target or ‘correct’ problems in these brain mechanisms. In this study, we test
the hypothesis that attention-related brain circuitry is overactive in anxiety disorders such that bright objects
and errors elicit increased activity compared to children with no disorder. We further predict this circuitry is
underactive in ADHD such that bright objects and errors elicit diminished activity increases. We hypothesize
that children with both anxiety and ADHD have an intermediate level of activity (similar to children with no
disorder), though less is known in this area. Finally, we predict that peer observation (a mild threat/stressor)
further exacerbates the overly active attention-related brain circuitry in children with anxiety. To test these
hypotheses, we use cutting-edge neuroscience tools to provide a nuanced characterization of attention-related
brain circuitry in N=300 children ages 10-12 years with anxiety disorders (n=75), ADHD (n=75), both anxiety
and ADHD (n=75), and no psychiatric disorder (n=75). Children play a computer game during which we
measure how suddenly appearing objects capture their attention. Brain activity is measured using functional
MRI, pinpointing the specific brain locations that are disrupted; and electroencephalography (EEG), providing
precise timing information. We characterize attention-related brain circuitry when children are being observed
by a peer versus without this stressor. This study will provide a comprehensive description of circuit-level
mechanisms of altered attention in pediatric anxiety, ADHD, and co-morbid conditions, providing mechanistic
targets for novel treatment design. Results could ultimately have major public health impact, by assisting in the
design of new treatments for two of the most prevalent and impairing childhood psychiatric disorders.

Public health relevance
Anxiety disorders and ADHD are two of the most common forms of childhood mental illness, can be highly impairing, and both include disruptions in attention. The goal of this study is to provide an in-depth characterization of how attention-related brain networks operate differently in children with anxiety disorders, ADHD, and both anxiety and ADHD compared to children with neither of these disorders. The results of this study are likely to assist in developing new treatments for pediatric anxiety and ADHD based on targeting these network-level disruptions.